A rapid, low-cost, point-of-consumption detection device for gluten in food.

PROJECT SUMMARY
Allergy Amulet, Inc. is committed to providing greater food transparency with a rapid, portable,
point-of-consumption gluten detection device. Gluten poses a significant and growing risk for the
millions of Americans living with gluten-related disorders, with symptoms ranging from abdominal
pain to death. Sufferers of gluten-related disorders face higher anxiety and fear when consuming
food products prepared by others due to cross-contamination, misinformation, etc. A reliable,
portable device capable of accurately detecting gluten-containing foods and ingredients would be
a vast improvement on the status quo. The proposed technology will serve as a supplemental
management tool for users by enabling them to directly sample their food for unwanted
ingredients and providing an additional layer of assurance that foods prepared by others are safe.
The objective of this Phase I effort is to demonstrate the feasibility of a low-cost electrochemical
sensing platform capable of detecting gluten in complex foods. Toward this objective, Phase I
encompasses the following Specific Aims: 1) develop a sensing platform for selective detection
of gluten; 2) validate the sensors against a diverse array of whole foods. The Principal Investigator
on this project, Dr. Dan Sundhoro, has extensive experience in the design of bioconjugation and
sensing platforms in complex backgrounds. Allergy Amulet, Inc. focuses on allergy detection and
related technologies, and has carried out market research and established strategic partnerships
within the allergy community and plans to commercialize the device. The company will oversee
the feasibility study and commercialization aspects of the project.
Relationship to Phase II Work: Successful completion of Phase I aims will allow us to pursue
Phase II funding, which will be used to further optimize the sensor technology for sensitivity and
specificity and advance the commercialization of the device for consumer use. Allergy Amulet will
leverage its existing investor network and board of directors, including allergists, doctors,
healthcare executives, scientists, seasoned entrepreneurs, and extensive connections across
myriad industries will help ensure a successful transition to market. Successful commercialization
will result in a product with high market value that could help prevent thousands of emergency
room visits per year and potentially save lives.

Public health relevance
PROJECT NARRATIVE Inadvertent ingestion of gluten poses a potentially fatal risk for the millions of Americans living with gluten-related disorders (GRDs). As there is currently no effective preventative solution for GRD sufferers other than strict avoidance, a reliable, portable device capable of accurately detecting gluten in food products would be a vast improvement on the status quo. Giving consumers the ability to rapidly test food for gluten with a portable device would enhance the quality of life for affected individuals and reduce the personal anguish, anxiety, and health care costs associated with treating GRDs.